Clinical Trials Reporting Porgram (CTRP) Program and Technical Support Services

To provide funding for National Cancer Institute for Biomedical Informatics and Information Technology Clinical Trials reporting Program and Technical Support Service requirement as well as extending Contract #HHSN316201200117W Order No. D1PD00826 if necessary.